BLRD Research Career Scientist Award Application

PROJECT SUMMARY / ABSTRACT: Dr. Ngan F. Huang, PhD is a Research Biomedical Engineer whose
translational research program focuses on cardiovascular diseases and traumatic muscle injury, both of which
are highly relevant in Veteran populations. The overall goal of her research program is to develop novel
therapeutic strategies to improve tissue regeneration and functional restoration to cardiovascular and skeletal
muscle diseases/injuries experienced by Veterans. These therapeutic strategies are aimed to reduce mortality
and improve the quality of life of Veterans. The primary focus area of her laboratory's research program is to
study the role of biochemical and biomechanical cues within the extracellular matrix in modulating cell fate and
tissue function, in order to translate the basic insights into novel therapies that promote cardiovascular and
skeletal muscle regeneration in Veterans. Her active VA BLR&D Merit award focuses on the treatment of
traumatic muscle injury using engineered skeletal muscle that better mimics the physiological organization and
vascularization of native skeletal muscle. In particular, she employs parallel-aligned nanofibrillar collagen
scaffolds to guide the organization and synchronized contractility of newly formed muscle fibers. Additionally,
inter-cellular interactions between skeletal muscle progenitor cells and vascular endothelial cells create a
vascularized muscle tissue that can undergo anastomosis upon transplantation. Her laboratory reports seminal
knowledge in that treatment of pre-endothelialized and parallel-aligned engineered skeletal muscle induces more
de novo muscle regeneration, organized myofiber structure, and perfused vasculature, than in engineered
muscle lacking pre-endothelization or spatial patterning. Proteomic and transcriptomic analysis reveal new
insights into the basic signaling pathways and cytokine profile that mediate this process. In a parallel strategy
to augment muscle regeneration, she also developed off-the-shelf scaffolds with controlled release of muscle
reparative factors that can be transplanted to the site of VML in conjunction with regenerative rehabilitation. With
funding from an active VA RR&D Merit award, she merges rehabilitative exercise with the transplantation of
aligned nanofibrillar scaffolds that release pro-myogenic factors to improve vascularization, neuromuscular
junction formation, and force generation. These research findings impact the treatment of volumetric muscle
loss by synergizing therapeutic cells, instructive biomaterials, and rehabilitation to promote muscle regeneration.
Besides skeletal muscle, another research focus area is the treatment of peripheral arterial disease using
strategies to induce revascularization. In an active NIH R01 grant, she demonstrates that spatially aligned
nanofibrillar collagen scaffolds serve as effective carriers to enhance the pro-survival and pro-angiogenic
function of transplanted therapeutic cells, leading to the restoration of blood perfusion in murine models of
peripheral arterial disease. The insights gained from the pro-survival effects of aligned nanofibrillar collagen
scaffolds have now been patented. In a parallel strategy, she develops protein mimetic hydrogels with tunable
stiffness to improve the survival of human induced pluripotent stem cell-derived endothelial cells upon injection
mice animals with peripheral arterial disease. She demonstrates that endothelial survival within the ischemic
limb of mice with peripheral arterial disease is significantly higher when delivered within the protein hydrogel than
in saline. Moreover, the hydrogel promotes induced pluripotent stem cell-derived endothelial cell secretion of
angiogenic paracrine factors, which contribute to the formation of more microvasculature. This work is now being
further developed in another active NIH R01 grant to study the role of stress relaxation mechanical properties of
hydrogels in modulating endothelial cell survival and revascularization. In summary, during the past 10 years at
the VA Medical Center, she published 75 peer-reviewed publications and patents. She has a strong commitment
to service to the local and national VA, training of VA mentees, and collaborative research with VA and affiliate
investigators.

Public health relevance
NARRATIVE Dr. Ngan F. Huang's translational research program focuses on cardiovascular disease and traumatic muscle injury, both of which are highly relevant in Veteran populations. The goal of her research program is to develop novel therapeutic strategies to improve tissue regeneration and functional restoration to cardiovascular and skeletal muscle diseases/injuries experienced by Veterans. Active research awards from the Department of Veteran Affairs and National Institutes of Health seek to develop engineered tissues with spatially patterned biomaterials that direct cell fate and tissue function, the engineering of vascularized tissues for improved skeletal muscle tissue survival and function, and the development of synthetic hydrogels with controllable mechanical properties that modulate the survival of transplanted tissues for treatment of peripheral arterial disease. If successful, these studies will impact Veteran care by reducing mortality and improving the quality of life.